Structure-function Studies Of Dna Polymerases

Summary of Work: We are examining the relationship between the structures of DNA polymerases and their functions, including fidelity. Accomplishments this year include the following. We determined that the fidelity of a archeal Y family DNA polymerase (Sso Dpo4) is very low. We also provided evidence that nucleotide misalignment in the active sites of this and likely other TLS polymerases generates frameshift mutations. We discovered that Pol lambda (family X) has 5'-dRPase activity and other properties suggesting its participation in base excision repair of DNA damage resulting from environmental stress. We collaborated with the NMR group to determine the NMR structure of the 8 kDa dRP lyase domain of DNA polymerase lambda. Based on structural information and biochemical properties, we proposed and tested a model for altered interactions of the polymerases active site with the DNA minor groove that explains the unusual base substitution error specificity of the (Family A) Klenow fragment of E. coli DNA polymerase I containing an amino acid replacement in the binding pocket for the nascent base pair. We presented evidence that DNA polymerase eta also likely participates in somatic hypermutation of immunoglobulin genes, a process responsible to development of high affinity antibodies. We presented evidence that a specific tyrosine residue in the site of DNA polymerase eta participates in determining the limited base selectivity of the highly inaccurate enzyme, as well as in the efficiency with which it bypasses a helix-distorting UV photoproduct. This study has implications for the ability of pol eta to strongly suppress human susceptibility to skin cancer. In collaboration with the Wilson group, we further characterized the dRP lyase activity of pol iota and localized this activity by controlled proteolysis of the recombinant protein expressed in insect cells. In collaboration with the Copeland group we discovered that, in the gene for the mitochondrial replicative DNA polymerase gamma, an active site point mutation that is associated with the human genetic disease Progressive External Opthalmoplegia encodes a polymerase with reduced catalytic efficiency and reduced DNA replication fidelity.